OnLine Catalog Access to the Parker Medical Library

DESCRIPTION (provided by applicant): Grady Memorial Hospital is a private, not-for-profit, acute-care community hospital serving Delaware County, the fastest growing county in the state of Ohio and, at last report, the 14th fastest growing in the United States. It is the only hospital in Delaware County. The Parker Medical Library provides current clinical and consumer health information for Grady Memorial Hospital’s physicians and employees as well as the general public. The long-term objective of this proposed project is to provide an online catalog of the Parker Medical Library’s materials on the Hospital’s existing network and future website so that ultimately users can have easier access to health information. In order to do this, a Winnebago Spectrum CIRC/CAT software system will need to be installed on the network. A barcode reader and OCLC access will be included with the network license fee. To support the software, a new Gateway 7210 server will need to be added to the internal network. The Principal Investigator will work with the Winnebago representative to install the software and take the free customer training. The PI will then be responsible for training the end-users. The Co-Investigator will be responsible for installing the new server, participating in the software installation and providing ongoing technical support for the system.